EPIDEMIOLOGY OF HUMAN RETROVIRUSES IN BLOOD DONORS

The contractor shall serve as the coordinating center for the Epidemiologic Studies of Human Retroviruses in Volunteer Blood Donors program. The objectives are as follows: 1) determine the prevalence of retrovirus seropositivity in first time blood donors; 2) determine the rate of retrovirus seroconversion in repeat blood donors as a measure of incidence of infection; 3) ascertain risk factors for antibody-positive donors; 4) characterize the blood population by geographic location, age, sex, race/ethnicity, and donation history to permit analysis on prevalence incidence, and risk factors: 5) identify recipients of retrovirus-positive blood units and conduct clinical and laboratory follow-up of these recipients to determine the transmissibility of these agents via transfusion; and 6) establish blood specimen repositories for long-term storage of specimens from study donors and recipients for future testing.